PUBLICATION OF PAPERS ON ALCOHOL &THE FAMILY

The purpose of this contract is to advance prevention research on alcohol and the family by insuring dissemination of the proceedings from the NIAAA hosted workshop "The Family and Alcohol: Opportunities for Prevention" to researchers in the alcohol field. This will be accomplished by contracting with a major journal in the field of alcohol research to publish these manuscripts as a supplement to The Journal of Studies on Alcohol.